CAI2R Administration

Administration Project Summary
The broad mission of our Center for Advanced Imaging Innovation and Research (CAI2R) is to bring
together collaborative translational research teams for the development of high-impact biomedical imaging
technologies, with the ultimate goal of changing day-to-day clinical practice. Our administrative component
supports this mission by a) maintaining efficient and effective day-to-day operations, b) promoting robust
communication among our staff and our various stakeholders, and c) providing thoughtful strategic guidance
informed both by external expertise and by ongoing self-evaluation.